Computational Core

COMPUTATIONAL CORE: PROJECT SUMMARY
The overarching goal of the Computational Core is to provide robust and reproducible analysis of high-throughput
genomic (WES), epigenomic (ChIP-seq, ATAC-seq, single-cell ATAC-seq), chromatin conformation (Hi-C, Hi-
ChIP and 4C) and transcriptomic (RNA-seq and single-cell RNA-seq) data using a variety of established
computational workflows. As described in the Core Research Strategy, the data will be uniformly processed by
well-established computational pipelines for standard analyses and advanced computational methods, including
machine learning, published recently by our group. The Computational Core is designed to provide start-to-finish
standardization of the analysis of sequencing datasets, rigorous data quality assessment, integration, and
visualization, as well as statistical expertise. The results of the bioinformatics analyses conducted in the Core
will be used by all three Projects, with the shareable workflows of our computational platform. The Computational
Core will analyze all the sequencing data generated by the Genomics Core using established best practices and
computational pipelines. Existing infrastructure at NYU Grossman School of Medicine will be used to ensure
seamless hand-off of all the data via the storage and computing environment provided by the NYU High-
Performance Computing Facility. This infrastructure has been in place for several years now and greatly
facilitates data exchange between the Genome Technology Center (GTC) and the Applied Bioinformatics
Laboratories (ABL) at NYU Grossman School of Medicine. Finally, the bioinformatics staff has set up and will
maintain a data exchange portal for the data and analyses that is accessible to all members of the proposed
study. This data exchange portal will also facilitate data sharing with the broader scientific community and the
public when our studies are published.

Public health relevance
COMPUTATIONAL CORE: NARRATIVE The dramatic decrease in the cost of high-throughput genomics technologies has rapidly expanded our understanding of the molecular underpinnings of cancer. However, as the scale of such data increases and becomes more diverse, data management, computational analysis and interpretation can be the major bottle- neck. The Computational Core will not only provide robust and reproducible analysis of high-throughput genetic, epigenetic, chromatin conformation and transcriptomic data, but will also use data integration techniques to help elucidate the role of chromatin architecture in tumor initiation and progression.